TAS::75 0850::TAS RECOVERY ACT ACTNOW CLINICAL TRIAL SUPPORT - CTEP IT Support

The purpose of this contract is to develop, maintain and expand the existing cancer therapy evaluation program and enterprise information systems (CTEP-ESYS) to support the NCI research community